Improving recovery for young adults living with serious mental illnesses using music-based self-management strategies: A mixed methods study

PROJECT SUMMARY. Nearly 4 million U.S. young adults aged 18-25 living with serious mental illnesses (YA-
SMI) are at heightened risk for negative outcomes, particularly those who are minoritized, low-income, and
experience complex trauma. Enhancing recovery for YA-SMI is, therefore, of great public health significance.
In this study, recovery is defined as clinical recovery (i.e., symptoms), and personal recovery, which is a
multidimensional process toward hope, meaning, and empowerment while managing symptoms. A key aspect
of recovery is the development of self-management (SM) to reduce symptoms and enhance quality of life.
Since young people spend nearly 40 hours a week listening to music, its potential as a SM strategy cannot be
overlooked. Music is a widely used strategy for maintaining wellness because it is accessible, appealing, and
culturally relevant. Yet, little is known about the mechanisms that may explain how music use influences
recovery for YA-SMI. In response, NIMH partnered with the Sound Health initiative and the Trans-NIH Music
and Health Working Group calling for mechanistic studies that address how music use can promote health and
wellness. Informed by the Neurosequential Model of Therapeutics and Social Determinants of Mental Health
(SDMH), this study uses an explanatory sequential mixed methods design to advance knowledge on how
music use may influence recovery among YA-SMI. It will enhance our capacity to conceptualize and measure
unique dimensions of personal recovery and apply experimental therapeutics (ET) to uncover how music use
affects recovery. This study has three aims: 1) Identify key dimensions of personal recovery among YA-SMI by
(a) evaluating the factor structure of the Recovery Assessment Scale (RAS) and (b) exploring in-depth the
meaning of the identified factors to deepen our understanding of YA personal recovery; 2) Describe variation in
healthy and unhealthy music use by key sociodemographic factors, SDMH, and recovery outcomes; 3) Apply
ET to uncover (a) how music use influences hypothesized mediators and (b) the consequences of such ‘target
engagement’ on recovery outcomes. Aim 1a uses secondary data from the sponsor’s NIMH study on YA-SMI
(N=121) to factor analyze the RAS. A confirmatory factor analysis (CFA) will be conducted using structural
equation modeling (SEM) to evaluate the five-factor structure among YA-SMI. Results will inform the collection
and analysis of primary data with a Youth Advisory Board (N=6); we will recruit a purposive sample of YA-SMI
(N=60 quantitative scales and subsample of N=25 qualitative interviews) in New York City. Aim 1b analyzes
qualitative data on personal recovery using thematic analysis. Aim 2 analyzes mixed methods data on music
use with thematic analysis, descriptive, and bivariate analyses. Aim 3 analyzes mixed methods data to uncover
how music may affect recovery using grounded theory, descriptive, and bivariate analyses. Data will be
integrated using the joint display method. This F31 involves substantive and methodological training and will
identify promising targets that will initiate a program of research to co-create novel interventions for YA-SMI.

Public health relevance
Project Narrative: Nearly 4 million U.S. young adults aged 18-25 living with serious mental illnesses (YA-SMI) are at heightened risk for negative outcomes, particularly those who are low-income and experience complex trauma. The proposed study uses an explanatory sequential mixed methods design to (a) extend knowledge on how we conceptualize and measure key dimensions of personal recovery among YA-SMI and (b) apply an experimental therapeutics approach to uncover how music use may influence personal and clinical recovery outcomes. This F31 involves substantive and methodological training and will identify promising targets that will initiate a program of research to co-create youth-oriented interventions to improve recovery among YA-SMI.